Cardiac Output and Renal Perfusion Alterations in the Development of Acute Kidney Injury in Cardiac Surgery

PROJECT SUMMARY
Dr. Lee Goeddel is a cardiac anesthesiologist and intensivist at Johns Hopkins University (JHU) with the long-
term goal of becoming a leader in perioperative organ protection. He is developing expertise in data science
methodologies, urine biomarkers of renal tubular injury, and ultrasound imaging of renal blood flow to better
understand the role of hypoperfusion-related acute kidney injury (AKI) during cardiac surgery. Up to 39% of
cardiac surgery patients experience AKI which drastically increases their risk of death or chronic kidney disease.
Though animal and human studies have demonstrated that low cardiac output (CO) can impair renal perfusion
and cause AKI, the relationship between CO, renal perfusion, and AKI in cardiac surgery is unclear. His long-
term research goal is to determine the optimal approach to monitor and treat CO and renal perfusion to prevent
AKI. This proposal addresses this gap and will provide the structured mentorship and necessary expertise to
achieve his goals. He has assembled an exceptional team of committed mentors at JHU. Co-primary mentor
nephrologist Chirag Parikh, MD, PhD, is a leader in AKI research and founder of the TRIBE-AKI consortium. Co-
primary mentor, biostatistician Karen Bandeen-Roche, PhD, has broad expertise in the mechanistic analysis and
modeling of complex diseases. Co-mentor Ciprian Crainiceanu, PhD, pioneered analytic tools to assess high
dimensional time series data to address public health problems. Co- mentor Charles Brown MD, MHS is a cardiac
anesthesiologist and PI of an NIH-funded cohort study examining cerebrovascular perfusion in cardiac surgery.
Cardiology co-mentor, Joao Lima, MD, has served as PI in several multicenter studies using novel imaging
methods. Dr. Goeddel will learn critical skills in clinical investigation, biostatistics, and AKI pathophysiology and
complete a PhD synchronized to the learning plan. This will uniquely position him to dissect the mechanisms of
AKI in the controlled environment of the operating room. The exceptional environment at JHU is ideal for Dr.
Goeddel’s growth. His research will clarify the association between low CO and AKI in a large cardiac surgery
cohort (data science- Aim 1) addressing the role of all key factors (like vasopressors). Dr. Goeddel will calculate
continuous CO (every 5 seconds) from arterial blood pressure (120 Hz) in a stored cohort using an FDA algorithm
that is clinically available and validated to the gold standard measurement of CO. In Aim 2, he will enroll the
HARBOR-AKI (Hemodynamics and Renal Biomarkers to clarify OR associated AKI) prospective cohort to assess
the association between low CO and urinary biomarkers of renal tubular injury that rise sooner after injury with
more sensitivity for ischemic AKI than serum creatinine to clarify the timing and physiology of CO related ischemic
AKI. In Aim 3, Dr. Goeddel will use standard ultrasound imaging during surgery to repeatedly measure renal vein
blood flow (3a) to relate renal perfusion to urine injury markers, and (3b) to explore the determinants of adequate
renal perfusion (independent and dependent of CO). The skills and knowledge Dr. Goeddel develops will enable
his goal to become an independent investigator prepared to lead key studies to prevent AKI in cardiac surgery.

Public health relevance
PROJECT NARRATIVE Low cardiac output (CO) is known to impair renal perfusion and cause ischemic renal injury, but methods have been unavailable to assess continuous CO and renal perfusion in cardiac surgery even though they may be modifiable with available treatments to reduce acute kidney injury (AKI). This proposal will use novel methods to measure and model continuous CO, renal perfusion, and AKI, to elucidate the timing of renal injury and the parameters of CO and renal perfusion at which injury occurs during surgery. Importantly, this proposal will develop Dr. Lee Goeddel as an independent investigator in the area of perioperative organ protection and prepare him to lead future studies to substantially reduce AKI in cardiac surgery.